Regulation of nucleus accumbens neurons by sleep and circadian rhythm

PROJECT SUMMARY
Adolescence is a vulnerable period for initiating substance use and abuse, during which time sleep and circadian
rhythm disruptions are pervasive. It is increasingly recognized that sleep and circadian rhythm causally, and
powerfully regulate reward processing, but the underlying mechanisms remain poorly understood. Could sleep
and circadian rhythm traits be related to reward circuit function? Whether and how do sleep and circadian
disruptions lead to increased vulnerability for substance use in adolescents? The central hypothesis of the Center
application is that adolescent development acts on underlying sleep and circadian traits to modify homeostatic
sleep drive, circadian phase, and circadian alignment, which in turn impact cortico-­limbic functions critical to
substance use risk (e.g., reward and cognitive control). It is further hypothesized that specific manipulations of
sleep and circadian rhythms during adolescence will affect reward responsivity and cognitive control in either
positive or negative directions. This research project (Project 5) will focus on rodent models to determine the
cellular and synaptic mechanisms within the cortico-­limbic circuit through which sleep and circadian disruptions
alter reward processing. Specifically, the nucleus accumbens (NAc) is a reward-­processing “hub” in the ventral
striatum which is sensitive to both sleep and circadian disruptions. For example, acute sleep deprivation reduces
glutamate release at medial prefrontal cortex-­to-­NAc medium spiny principal neurons (MSNs) synapses;; chronic
sleep fragmentation increases cholinergic neural activity in the NAc (preliminary results);; robust diurnal
fluctuations in AMPA receptor (AMPAR) levels and intrinsic membrane excitability are also observed in the NAc
MSNs, and circadian gene mutation in the NAc leads to altered AMPAR transmission in MSNs. Together, these
results suggest that the NAc may represent a converging site for sleep and circadian rhythm to regulate reward
processing. Accordingly, Project 5 will test the hypothesis that sleep and circadian rhythm target aspects of NAc
synaptic transmission and neural modulation to regulate reward-­motivated behaviors. Thus, Aim 1 will use
genetically diverse outbred rats to determine whether naturally occurring “early” and “late” chronotypes are
associated with different diurnal variation of AMPAR transmission in NAc MSNs. This aim will accommodate
molecular (Project 3) and behavioral (Project 4) characterizations of these rats. Aim 2 will determine whether
circadian disruptions without changes in sleep alter the diurnal variation of membrane excitability and/or
postsynaptic AMPAR levels in the NAc MSNs. Aim 3 will determine the effects of acute and chronic sleep
restrictions on adenosine and cholinergic transmission in the NAc, and the behavioral consequences in natural
or drug self-­administration. The expected outcome of Project 5 will integrate and extend findings from behavioral
(Project 4) and molecular genetic (Project 3) studies, which together will provide mechanistic insights to inform
and further develop human studies (Projects 1&2).